Clinical Research Network in Nonalcoholic Steatohepatitis

PROJECT ABSTRACT
Nonalcoholic fatty liver disease (NAFLD) and nonalcoholic steatohepatitis (NASH) represent a major cause of
liver disease morbidity and mortality. The NASH Clinical Research Network (NASH CRN) has been sponsored
by the NIDDK since 2002 and is an international leader in clinical studies of NASH. The overarching objective
of this application is to pursue clinical and translational research in NASH that will ultimately lead to
improvement in the management of patients with NAFLD and NASH. There remains a need to understand the
burden of liver disease and other causes of morbidity and mortality in NASH. New medications for adults with
NASH are currently in clinical trials but no therapies are currently in development for children. Thus there is a
need for the NASH CRN to continue our leadership in clinical trials for NASH. This application is for the
Continuation of the Seattle Clinical Center of the NASH CRN, which has been part of the NASH CRN since
2002 and represents a large geographic area with a unique patient population. Several specific aims are
proposed that will advance the objectives of the NASH CRN during the next period of funding. We will
continue enrollment and longitudinal follow-up of NAFLD and NASH patients in the adult and pediatric
Database studies, which include over 3,000 adults and children with biopsy-proven NASH. Detailed
information about recruitment and retention plans are provided. The STOP-NAFLD clinical trial has begun
enrollment and will examine the safety and efficacy of losartan for pediatric NASH. We will actively contribute
to this study through our collaboration with Seattle Childrens Hospital. We will also actively participate in adult
NASH trials and make these studies a priority at our clinical center. A translational aim has been proposed
that will utilize the biospecimens and clinical data of patients in the Database studies to examine the role of
hepatic iron deposition on innate immunity and relationship to NASH progression. We also describe new
transcriptomic studies in NASH via a new collaboration with the Institute for Systems Biology that will provide
mechanistic insights and a systems approach for the study of NASH. Finally we propose a clinical trial of low-
dose vitamin E in patients with and without type 2 diabetes. Although vitamin E was shown to be effective in
the PIVENS trial, safety concerns have been raised with higher doses and there are few controlled trials
examining its efficacy in patients with diabetes. The PI and Seattle Clinical Center have been leaders in the
NASH CRN since its inception and we remain fully committed to ensuring the success and impact of this
network in improving liver health and advancing the mission of the NIDDK.

Public health relevance
PROJECT NARRATIVE Nonalcoholic fatty liver disease (NAFLD) and nonalcoholic steatohepatitis (NASH) represent a major cause of liver disease morbidity and mortality in the USA. The NASH Clinical Research Network (NASH CRN) has made substantial contributions to the understanding and treatment of this condition over the past 16 years. The goal of this application is to seeking funding to continue the NASH CRN to help improve the care of patients with this liver disease.